Emerging Trends in the Chemistry of Cannabis Vaping and Toxicant Emissions

The prevalence of cannabis vaping, especially among young people, continues to outpace the
understanding of its impact on public health. The frequency of vaping cannabis among
adolescents from all demographic groups was recently reported as ≥ 6 times per month, and is
rising faster than occasional use. Cannabis concentrates (CCs), also termed extracts or oils, are
among the most common and potent cannabis vaping formulations. CCs are typically highly
enriched in cannabinoids such as THC or CBD. THC concentrations in CCs are ~50-90% (w/w),
while the THC content in cannabis plant material for smoking is 10-25%. Currently, the number
of new CC formulations continues to grow, including the emergence of previously unknown
semi-synthetic cannabinoids, many of which are currently legal and readily available. The
overarching goal of this project is to bridge significant knowledge gaps including understanding
how specific chemical formulations and vaporizer designs exacerbate toxicant formation. To
address these issues, new analytical methodology will be developed to determine the origins of
toxic emissions. A main toxicant prioritized for study in the application is ketene, a violently
reactive, potentially deadly poison gas with high pulmonary toxicity. The specific aims of the
proposed study are:
1. Determine chemical sources of ketene emissions during vaping
2. Determine the device-related parameters that modulate toxicant emissions.

Public health relevance
The proposed project is relevant to public health because it aims to address gaps in knowledge concerning the poten�al harms of vaping manufactured cannabis products. The project is relevant to NIDA’s mission because it will aﬀord improved understanding of toxicant emissions that can aﬀect individual and public health.